Characterizing determinants of cellular senescence and epigenetic dysregulation on tobacco smoke exposure in lung

Project Summary/Abstract
Cigarette smoking is the main cause of occurrence of Chronic Obstructive Pulmonary disease (COPD).
Studies show that cigarette smoke (CS)-mediated increase in cellular senescence causes premature ageing in
the lung, thereby leading to the development of COPD. However, the exact mechanism of disease
development via alterations in cellular senescence over a prolonged period in CS-induced COPD is not known.
In this respect, various inter-individual variations are observed amongst regular smokers, thus indicating
potential involvement of epigenetic regulations in modulating the downstream signaling. Considering this I
hypothesize that the epigenetic regulation of cellular phenotypes and gene expression of cellular senescence-
associated genes (p16, p21 and p53) drives disease-fate towards emphysema upon chronic CS exposure.
To test this hypothesis, I propose to: (1) determine the time (1, 3, and 6 months(mo)) and age-dependent
(2mo versus 18 mo) effects of CS-exposure on the lung cellular senescence and associated epigenetic
regulation in vivo using SNARE-sequencing (K99 phase), and (2) study the determinants of cellular
senescence and associated epigenetic mediators in primary human small airway epithelial cells (SAECs) from
healthy and diseased (COPD) individuals (R00 phase). My postdoctoral work has shown that clearance of
senescent cells results in reduction of CS-induced neutrophilic inflammation and reversal of alveolar wall
damage in mouse model (p16-3MR). Thus, studying the CS-induced changes in the lung neutrophil and
epithelial cell population is the focus of this project. Upon completion of these aims, I will be able to identify
gene targets and associated chromatin sites that are altered on cigarette smoking and associate them with
disease development in COPD. Use of two mouse models (C57BL/6J and p16-3MR) will help in understanding
the role of p16-dependent senescence in CS-mediated alterations in the lung. Additionally, use of Multiome
(SNARE-seq) technology in Aim1 will provide a chance to identify unique cell phenotypes based on
differentially expressed genes and correlate them to the epigenetic signatures within the cell upon CS
exposure. These results would lead to future publications, collaborations, and grant proposals, thus helping to
launch my career as an independent researcher in the field of lung biology.

Public health relevance
Project Narrative The goal of this project is to understand the temporal and age-dependent changes in the cellular senescence phenotype amongst smokers to get a better understanding of the disease pathogenesis in Chronic Obstructive Pulmonary Disease (COPD). Deciphering this will help establish the role of cellular senescence (p16- dependent or independent) and associated epigenetic alterations leading to detrimental neutrophilic lung inflammation and alveolar wall damage in COPD. These mediators can then develop as potential targets for early detection and/or development of effective therapy in CS-associated COPD.